Defining the impact of developmental herbicide exposures on gut microbiome physiology and interactions with health

This project will define how interactions between herbicide exposure, the microbiome, and the host promote
adiposity. Billions worldwide are overweight or obese. The gut microbiota regulate host energy metabolism, and
imbalance in these communities correlates with increased body mass, adiposity, and altered lipid metabolism.
Common herbicides are known potent disruptors of gut microbial communities and the patterns of microbial
community disruption induced by herbicides are consistent with those that manifest in obese individuals.
Moreover, disruption of the gut microbiota during key developmental windows has been linked with increased
risk of obesity. However, it remains unclear if herbicide induced disruptions of gut microbiomes or their
functioning yields obesogenic effects. We hypothesize that early life exposure to environmentally relevant
concentrations of three widely used herbicides (glyphosate, atrazine, and 2,4-D) induces disruption of the
microbiome favoring the assembly of a microbiota that contributes to elevated adipogenesis. We propose a
series of innovative experiments that integrate multiomic microbiome data with measures of host physiology to
identify herbicide disrupted microbial pathways that correlate with adiposity. Germ-free animals, microbiome
transplants, and in vitro assays will allow us to resolve causal relationships between microbiota and obesity.
Additionally, this project will define the role of the gut microbiome in mediating the acute toxicological effects of
herbicide exposure, identify the molecular pathways that mediate this functioning, and isolate and characterize
the microbes responsible for its execution. Consequently, the proposed work will clarify herbicide exposure
hazards by defining concentrations that sufficiently disrupt microbiota to contribute to obesity, define mechanistic
links between herbicide associated microbiome disruption and adiposity, and propel subsequent research in
mammals towards generating microbiome targeting or mimicking therapeutics capable of preventing or treating
obesity.

Public health relevance
Widespread and increasing developmental exposure to common herbicides has been linked to microbiome disruption and there is growing concern that herbicide induced alteration of gut microbial communities may contribute to the development of obesity. This project will identify gut microbiota, microbial genes, and metabolites that link with adiposity through the disruption of adipogenesis. The long-term goals of this work are to determine the role of the microbiome in the mediation of the obesogenic effects of herbicides, define the role of the microbiome in mediating the acute toxicity of herbicides, and to identify candidate microbes or microbial products that mitigate the effects of herbicide exposure on host physiology.